Evaluating causes for failure to thrive in a Noonan-like syndrome with loose anagen hair (NSLH) patients using NSLH vertebrate model

Summary
Even though the genetic basis of RASopathies has been acknowledged for more than a
decade, the development of therapies that radically improve clinical outcomes for RASopathy
patients has not rapidly progressed. Failure to thrive, gain weight, and grow are common
symptoms of RASopathies, but the underlying causes of these symptoms are not known. Our
lab is studying a RASopathy called Noonan syndrome with loose anagen hair (NSLAH), where
patients suffer from delayed development of the gastrointestinal system and perturbations in
metabolic pathways. In these studies, we will use zebrafish as a vertebrate model to investigate
how mutations in the shoc2 gene, found in patients with NSLAH, affect the early stages of
gastrointestinal development and metabolism. Zebrafish offer distinct advantages for
development studies, including their transparency and rapid external development. Thus,
determining how metabolic perturbations affect this clinically relevant model's growth and
developmental patterns will lead to better treatment for patients with NSLAH. These insights
could identify oral supplements for patients, similar to what recently was found for congenital
disorders of glycosylation and neonatal hypoxia-ischemia patients. While this work focuses on a
specific RASopathy, our findings will impact other RASopathies where patients present with
similar difficulties to thrive. The proposed work will also establish a foundation for successful
future studies focused on developing specific strategies for therapeutic approaches in
RASopathies.

Public health relevance
Public Health Relevance Statement Rare diseases collectively affect approximately 25-30 million people in the United States and disproportionally affect children. The proposed work will result in a novel vertebrate model and insights into the pathogenesis of the rare developmental disorder Noonan syndrome with loose anagen hair. Ultimately, this work will provide a model for the future development of guidelines for the diagnosis and treatment of this rare disease and will lead to a better understanding of the etiology of a rare disease.